Optical Probes: Discovery to Application

The discovery of novel optical probes underpins myriad biological imaging approaches and assay technologies. This conference will explore the latest advances in the development of probes for elucidating biological processes. We aim to bring together researchers in the fields of chemistry, spectroscopy, molecular sensing, biological imaging and advanced imaging technologies in order to foster new collaborative projects. This meeting will provide opportunities to encourage and support junior investigators/trainees to launch innovative molecular probes and enhance our ability as a community to collectively tackle challenging biomedical questions.
This conference will bring together scientists engaged in a wide range of probe development and application efforts. Speakers and attendees will include a broad community of synthetic/ physical organic chemists, protein design experts, and biology/biophysics-oriented scientists.

Public health relevance
Narrative This grant will help to fund the second instance of a new conference dealing the discovery of optical probes for biological imaging. This conference will bring together scientists engaged in a wide range of probe development and application efforts. Speakers and attendees will include a broad community of synthetic/ physical organic chemists, protein design experts, and biology/biophysics application-oriented scientists.